The Role of 17β-Estradiol in Delirium

ABSTRACT
Delirium is frequently precipitated by urinary tract infection (UTI), a condition that
disproportionately affects older women and contributes to increased mortality, prolonged length
of stay, and accelerated long-term cognitive decline. Existing treatments for delirium center
largely on treatment of the precipitating cause, modification of environmental contributors, and
avoidance of deliriogenic medications; however, do not address the underlying pathobiology of
the condition.
We have developed a novel mouse model of UTI-induced delirium and generated compelling
preliminary data that demonstrate a potential role for exogenously administered 17β-estradiol in
mitigating UTI-induced delirium. These findings may explain, at least in part, why older women,
who after menopause have reduced levels of 17β-estradiol, are particularly susceptible to
developing delirium.
In this R21 application, we propose to use our novel mouse model of urinary tract infection-
induced delirium, oophorectomized mice, state-of-the-art behavioral testing, and genetically
modified mice to determine whether 17β-estradiol ameliorates the structural and functional
phenotypes of delirium via the G protein-coupled estrogen receptor 1. Given the lack of
evidence-based pharmacological treatments for delirium, the findings from this research could
have widespread clinical implications, including providing novel pre-clinical justification for
clinical trials using a short-term application of an existing drug, 17β-estradiol, to ameliorate UTI-
induced delirium and quality of life for millions of older women around the world.

Public health relevance
PROJECT NARRATIVE In this project, we propose to understand the role of 17β-estradiol in ameliorating urinary tract infection-induced delirium. Briefly, we will use our novel model of urinary tract infection-induced delirium, oophorectomized mice, state-of-the-art behavioral testing, and genetically modified mice to determine whether 17β-estradiol ameliorates the structural and functional phenotypes of delirium via the G protein-coupled estrogen receptor 1. Given the lack of evidence-based pharmacological treatments for delirium, the findings from this research could have widespread clinical implications, including providing novel pre-clinical justification for clinical trials using a short-term application of an existing drug, 17β-estradiol, to ameliorate UTI-induced delirium and quality of life for millions of older women.